Toward DNA Sequencing as a Primary Newborn Screen for Treatable Disorders not Amenable to Current Screening

We propose to evaluate whole exome sequencing (WES) and whole genome sequencing
(WGS) as an approach for population screening of early-onset treatable recessively inherited
conditions. Our analysis will be based on prior and additional work on the large, ancestrally
diverse cohort of children constituting all 1,334 cases of inborn errors of metabolism (IEM)
diagnosed by tandem mass spectrometry screening in California over an 8.5 year period.
Our prior analysis found that WES lacked adequate sensitivity and specificity to replace
current newborn screening by tandem mass spectrometry (MS/MS). A screening-optimized
DNA variant interpretation pipeline identified two known or likely pathogenic variants in most,
but not all, affected cases. The pipeline was 88% sensitive and 98.4% specific, numbers too low
to replace MS/MS. We found that 1/3 of known or likely pathogenic variants were novel, of
which roughly 2/3 were missense. Adequate sensitivity and specificity therefore require
accurate annotation of missense variants.
DNA variant annotation has focused on individual variants and is most applicable for
dominant disorders for which pathogenicity is determined by a single variant. For recessive
diseases, expression is determined by two variants on different chromosomes. We propose a
new framework for disease prediction in recessive conditions, in which the bi-allelic variants, or
diplotype, is used to assess pathogenicity. We will improve disease detection for autosomal
recessive diseases through screening utilizing DNA sequencing by 1) improving interpretation of
bi-allelic missense variants by using variant co-evolution, conservation, amino acid proximity
and other features to derive a risk score, 2) considering both variants in recessive pathogenicity
prediction, and 3) using the California newborn screening data set as a training set with a small
number of positives for each disorder and a large number of controls (those cases positive for a
different disease) to develop a machine learning algorithm to predict likelihood of disease. To
address sensitivity, for 103 exome negative IEM cases from our data set we will fully interrogate
the exome data, both for known IEM genes and also the entire exome to identify novel genes.
Finally, for those remaining unsolved, we will perform WGS to identify additional causal
variants. In so doing, we will also compare WES and WGS in terms of overall sensitivity and
specificity for screening.
We anticipate that the proposed study will be a significant advance in assessing DNA
sequencing as a newborn screening tool for those early-onset treatable diseases for which there
is currently no screening test, leading to decreased death and disability.

Public health relevance
We propose to improve DNA sequencing as a newborn screening test by increasing the sensitivity and specificity to an acceptable level for those early-onset treatable disorders for which there is no alternative screening test. Given the large number of early-onset treatable conditions for which there is no test, or for which current testing continues to miss cases, DNA sequencing has the potential to have a large public health impact. Current newborn screening for multiple inborn errors of metabolism by tandem mass spectrometry is able to detect 40-50 disorders and is considered to be among the ten greatest public health successes of the first decade of the 21st century by the Centers for Disease Control; DNA based newborn screening could greatly increase the number of disorders identified and lead to timely and disease-specific interventions, thereby further decreasing death and disability due to treatable, early-onset recessive disorders.